DIANEAL IN MALNOURISHED AMBULATORY PERITONEAL DIALYSIS (CAPD) PATIENTS

A multi-center study to determine the effect of supplemental amino acids on protein turnover and nitrogen balance in malnourished patients undergoing continuous ambulatory peritoneal dialysis.